An angiogenic role for the alpha 5 beta 1 and alpha V beta 3 integrins during cer

DESCRIPTION (provided by applicant): Ischemic stroke is a major cause of morbidity and mortality in the western world. Despite intensive research in this field, current options for treatment are still limited. One approach to preventing stroke or promoting recovery after stroke is to encourage the growth of new blood vessels (angiogenesis), to restore vascular delivery to the ischemic area. Angiogenesis is regulated by growth factors, cytokines, and extracellular matrix (ECM) proteins like fibronectin. The hypothesis to be tested by this proposal is that cerebral ischemia induces brain endothelial cell expression of the a5β1 and avβ3 integrins, and that fibronectin promotes cerebral angiogenesis, via these integrins. Studies outside the central nervous system (CNS) show that the a5β1 and avβ3 integrins are strongly induced on sprouting blood vessels, and functional blockade of these integrins inhibits angiogenesis in animal models of tumor formation and diabetic neovascularization. Evidence from our laboratory suggests that these integrins may also promote angiogenesis in the CNS: (i) developmental angiogenesis is strongly associated with brain endothelial expression of the a5β1 integrin, (ii) the a5β1 integrin is also strongly induced on angiogenic endothelial cells during hypoxia in the adult CNS, (iii) following cerebral ischemia, ¿1 integrin mRNA levels are increased in the ischemic penumbra, where new vessel sprouting occurs, (iv) the avβ3 integrin is induced on angiogenic endothelial cells rapidly following cerebral ischemia, and (v) in vitro studies of brain endothelial cells demonstrate that the survival and mitogenic effects of fibronectin are mediated by both the a5β1 and avβ3 integrins. The hypothesis will be tested using a combination of in vivo and in vitro approaches. Endothelial expression of the a5β1 and avβ3 integrins will be examined in mouse models of focal cerebral ischemia, and cerebral hypoxia. The role of the avβ3 integrin in cerebral angiogenesis will be directly examined in both animal models using β3 integrin null mice. Potential roles for the a5β1 and avβ3 integrins in regulating mouse brain endothelial cell behavior will be addressed by using endothelial cells deficient in these integrins. Finally, the time-course and cellular source of the pro-angiogenic factor, TGF-β1 will be defined in these systems. This study has three Specific Aims: 1) demonstrate induction of the a5β1 and avβ3 integrins on brain endothelial cells following ischemia or hypoxia in cerebral tissue; 2) demonstrate an instructive role for the a5β1 and avβ3 integrins in promoting brain endothelial cell survival, proliferation, migration, and capillary formation; and 3) define the time-course and cellular origin of the pro-angiogenic factor, TGF- β1 following cerebral ischemia and cerebral hypoxia. These studies will directly test the idea that the a5β1 and avβ3 integrins play an important role in promoting cerebral angiogenesis in response to ischemia. Based on this work, manipulation of the expression level or signaling of these integrins are likely to provide a promising approach to enhance cerebral angiogenesis, either before or immediately after ischemic stroke. PUBLIC HEALTH RELEVANCE: The overall aim of this Project is to examine the notion that cerebral ischemia induces endothelial cell expression of the a5β1 and avβ3 integrins, and that fibronectin promotes new blood vessel formation in the brain via these integrins. Based on this work, manipulation of the expression levels or signaling pathways of these integrins may provide a promising therapeutic approach to enhance cerebral blood vessel growth, either before or immediately after ischemic stroke. If successful, this work could have major impact on the incidence and mortality of ischemic stroke.